Sex-dependent aging mechanisms of retina and visual cortex

PROJECT SUMMARY:
Aging induces changes in the visual system, including decreased visual acuity, contrast and wavelength
sensitivity, and processing of visual information. These changes are reflected in retinal pigment epithelium
(RPE), retina and the visual cortex. RPE plays important roles in maintenance of the light-sensitive
photoreceptors. Age-related macular degeneration (AMD), which is the major cause of blindness in the elderly,
initially affects the RPE and gradually leads to secondary loss of photoreceptors. One of the two forms of AMD
is the “dry” form, for which currently there is no effective treatment. Consequently, there is an unmet medical
need for understanding the disease mechanisms during aging and developing new therapies for AMD. There is
a higher prevalence for AMD in women compared to age-matched men, and there are sex-related differences in
the pathophysiology of AMD. Specifically, sex hormone deficiency and its duration are associated with the
development and progression of soft drusen in women but not in men. Gonadal hormones have been related to
retinal disorders, and macular hole is reported to be more common among women than men, particularly in
postmenopausal women. Despite these reports, the Royal College of Ophthalmologists guidelines indicate that
the higher prevalence of AMD in female sex is due to their longer life expectancy and that female sex is not a
risk factor for AMD. Thus, whether gonadal hormones or sex chromosomes are risk factors in age-related retinal
degeneration remain elusive.
To determine the role that sex plays in age-related visual decline, we propose to
use the four-core genotype (FCG) mice, which will allow us to test the roles of sex chromosome complement
(XX vs. XY), female and male hormone secretions, and the combined or interactive effects of these factors on
RPE and visual cortex aging. The results of the proposed studies will further our understanding of how aging,
sex chromosomes, and gonadal sex contribute to the visual system function during aging.

Public health relevance
NARRATIVE: This proposal addresses critical issues of central importance to advance our understanding of the mechanisms of age-related decline in visual system. Those include: investigating how sex could play a critical role in RPE, retina and visual cortex functions during aging and how sex chromosomes, sex hormones, or their interactions could regulate the visual system function. The results and conclusions derived from this study will provide important information for better understanding the age-related changes in the visual system and will further our knowledge of how aging, sex chromosomes, and gonadal sex contribute to the visual system function during aging.